RFA-PS-23-004, Innovative Administration of Long-Acting Injectables for HIV Treatment Enhancement at Home (INVITE-Home)

ABSTRACT/PROJECT SUMMARY
There is high interest in long-acting injectable antiretroviral therapy (LAI-ART) among people with (PWH), with
many conveniences for uptake and persistence. While LAI-ART eliminate the need for daily pill-taking and
have the potential to help close critical gaps in HIV care, patients have expressed important barriers to
effective implementation and concerns that frequent clinic visits can exacerbate stigma, increase the risk of
unwanted disclosure, and lead to frequent disruptions in their daily lives. The need to travel to a clinic for
injection visits multiple times throughout the year can also be financially and logistically prohibitive for many
patients and can widen existing healthcare disparities. Similarly, clinicians worry that additional visits outside of
routine care may lead to missed appointments, decreased engagement in care, and put further strain on
limited clinic resources. Administration of LAI-ART by a trained layperson injector (such as family, friend, or
partner of the patient) can help mitigate some of these patient- and clinician-identified barriers. This model of
care has been used successfully in other contexts, but up to now it has not been evaluated for HIV treatment.
Alternative LAI-ART delivery methods have the potential to increase the PWH and layperson injector’s
confidence, empowerment, convenience, privacy, and self-management skills, and ultimately facilitate LAI-ART
uptake and persistence. INVITE-Home (Innovative Administration of Long-Acting Injectables for HIV Treatment
Enhancement at Home) will support the expansion of LAI-ART in non-clinical settings by developing,
implementing, and evaluating a comprehensive, theory-informed training to support the administration of LAI-
ART by a trained layperson injector. In Aim 1, we will design and develop an innovative, theory-based
layperson injector training to improve acceptability and uptake of LAI-ART in home-based settings. We will
qualitatively evaluate training barriers and needs of PWH, layperson injectors, and clinicians to develop the
training. In Aim 2, we will enhance understanding of home-based LAI-ART using the training developed in
Phase 1, by examining implementation and effectiveness of home-based LAI-ART injections. This study will
address a critical need to develop alternative and decentralized LAI-ART delivery methods that can mitigate
barriers to uptake and persistence, enhance the real-world LAI-ART effectiveness, reduce systemic and
structural inequities, address clinical and policy challenges, and close key gaps in HIV care.

Public health relevance
PROJECT NARRATIVE This study will support the expansion of long-acting injectable antiretroviral therapy (LAI-ART) in non-clinical settings by developing, implementing, and evaluating a comprehensive, theory-informed training intervention to support the administration of LAI-ART by a trained layperson injector (e.g., friend, family, partner identified by a person living with HIV). This study will address barriers to LAI-ART uptake and persistence, enhance real- world effectiveness, and help close critical HIV care gaps.